Analysis Core

PROJECT SUMMARY/ABSTRACT: ANALYSIS CORE
The overarching goal of the Analysis Core is to optimize the quality and relevance of research produced
through the Pilot Studies mounted by NERC/RCMAR Scientists. This Core draws on a well-established, team-
based approach to preparing young scholars in sophisticated analytic methods, on a rich array of existing data
relevant to the Center's thematic focus, and on synergies with a nation-wide network of sister universities that
complement this mission. It will ensure that Pilot Studies make efficient use of study resources, use methods
that maximize validity, and yield findings with clear and meaningful inference to the larger target populations. To
achieve this, Analysis Core members will be intimately involved in all aspects of the NERC/RCMAR effort. Our
team integrates diverse methods from epidemiology, biostatistics, medical anthropology, health economics,
health services and policy, and health outcomes research, and augments a robust quantitative capacity with
exceptional experience in qualitative methods specific to minority communities. Thus, the specific aims are to:
1) collaborate with the Research Education Component to implement analytic methods to optimize validity,
inference, and generalizability of Pilot Studies and grant applications; 2) ensure the reliability and validity of study
measures and minimize measurement error; 3) apply a flexible and comprehensive data analytic strategy for
basic cross-sectional and more complex data structures; 4) partner with Pilot Study NERC/RCMAR Scientists
and their mentors to maximize efficient use of Center resources; 5) as appropriate, assist Pilot Study
NERC/RCMAR Scientists in integrating qualitative and quantitative methods to contextualize and enhance the
cultural relevance and public health impact of their studies; 6) provide structured support and formal, didactic
instruction; and 7) continue to develop and critically evaluate a catalogue of data sets containing information on
the health disparities of older AI/ANs for use by past and present NERC/RCMAR Scientists. The Analysis Core
will be directed by Spero M. Manson, PhD (Pembina Chippewa), Distinguished Professor of Public Health and
Psychiatry, and director, Centers from American Indian and Alaska Native Health, School of Public Health,
University of Colorado, Anschutz Medical Campus (UCD/AMC). Dr. Manson is well known for his work in mixed
methods, with 40 years of experience integrating qualitative and quantitative investigative procedures that has
enriched the study of AI/AN health. Clemma Muller, PhD, Research Assistant Professor, School of Nursing, and
co-director of Partners for Native Health (P4NH), WSU, will co-lead this Core. An epidemiologist and
biostatistician, she joined NERC/RCMAR nearly 15 years ago as a mentor and now moves into a major role in
this effort. This transition reflects her leadership of the Methods and Analysis Core of two other NIH-funded
centers led by Drs. Manson and Buchwald. They and their team will maximize scientific rigor while
accommodating logistical and methodological challenges that arise in real-world research in Native communities.